Scalable, quantitative, single-cell CRISPR screens

PROJECT SUMMARY
Numerous large sequencing initiatives have produced catalogs of human genetic diversity. A major obstacle in
using these data to better understand health and disease is the vast scale of the human genome: for example,
there are ~22,000 protein coding genes, millions of candidate regulatory elements, and tens of millions of
common variants. This challenge has motivated the development of increasingly refined functional genomics
tools that enable many distinct hypotheses to be tested in parallel. For example, CRISPR screening libraries
enable every gene in the genome to be systematically knocked out, activated, or knocked down, providing a
means of testing how connect genes to phenotype. Though highly successful, these approaches are in one
sense rather wasteful: quantification usually amounts to counting the representation of the sgRNAs mediating
the perturbations by sequencing, meaning thousands of cells per gene are often used in practice to ensure
statistical power. This simple constraint means that screens are often conducted in only a handful of
conditions, limits applications to precious cell types such as patient samples, and makes scaling to larger
problems difficult. Here we leverage the explosion of recent innovation that has accompanied the
popularization of single-cell RNA sequencing to revisit the task of conducting CRISPR screens. We propose
Quantitative Reporter Sequencing (QRS), a highly scalable and highly quantitative approach for connecting
CRISPR-mediated genetic perturbations to their effects on an engineered phenotypic reporter in pooled format.
Using a simple library prep protocol that requires no special instruments, QRS enables CRISPR screens with
single-cell resolution and absolute quantification of phenotype. Each cell therefore serves as an independent
replicate measurement, reducing cell input requirements and enabling the measurement of distributions of
phenotype for each perturbation rather than average effects. Through applications we demonstrate how this
approach can be used to conduct highly sensitive screens for weak effects in precious cell types, to efficiently
quantify genetic interactions (i.e. emergent effects of perturbing multiple genes simultaneously), and to guide
the search for drivers of incompletely penetrant phenotypes. This platform will extend CRISPR-mediated
functional genomics to contexts and cell types that are currently intractable and enable experiments that are
“beyond genome-scale.”

Public health relevance
PROJECT NARRATIVE Though many human genomes have now been sequenced, the connection between the genetic code and disease risk and pathology remains largely unexplained. CRISPR screens, which systematically quantify how every gene in the genome affects a phenotype, provide one powerful tool for addressing this challenge. Here we propose an improved technique for conducting these screens by leveraging recent technological advances: Quantitative Reporter Sequencing. By making CRISPR screens more “cell-efficient,” we enable experiments in precious or intractable cell types and enable experiments that can test many more hypotheses.